Center for Biomedical and Minority Health Research

Project Summary
African Americans comprise a high burden of all new HIV diagnoses in Houston, Texas. To reduce
new cases of HIV, it is crucial to increase accessibility to HIV testing, risk assessment and
reduction counseling, and linkage to care, including pre-exposure prophylaxis (PrEP) or link to
HIV care. Community pharmacists are highly accessible in terms of locations and extended
business hours. Community pharmacies are often perceived as non-stigmatized environments,
have private space for encounters, and can reach poor or racial minority neighborhoods.
Pharmacists can provide point-of-care testing waiver by Clinical Laboratory Improvements
Amendment and medication prescribing under collaborative practice agreements. The
agreements lay the groundwork for expanding pharmacy-based HIV testing and PrEP services.
African American communities in the South are particularly burdened due to poor healthcare
access and heightened stigma. Texas Southern University (TSU) is one of the nation's largest
historically black colleges and universities (HBCUs) and the only HBCU in the State of Texas
offering a pharmacy program. Each year, there are a large number of African American healthcare
professionals graduate. TSU has established unparalleled trust within the African American
community, with a longstanding history of successfully executing community engagement and
outreach activities and productive partnerships with various community-based organizations.
Therefore, we propose the Pharmacists Conquering HIV and Maximizing PrEP (CHAMP) program
in collaboration with Texas Developmental Center for AIDS Research, the Houston AIDS
Education and Training Center, and the Texas Implementation Science Hub to End HIV. We aim
to develop a pharmacy-led HIV testing and prevention services model to overcome the current
barrier to access to care for African American community. We proposed the following aims: Aim
1: Identify barriers and facilitators to pharmacy-led HIV testing and PrEP; Aim 2: Develop and
pilot pharmacy-led HIV testing and PrEP in a pharmacy serving predominately low-income African
American communities with high HIV prevalence. We anticipate that completing these aims will
identify potential barriers and facilitators of implementing pharmacy-based HIV testing and PrEP
in African American Communities. The results of this study will inform future studies to develop
implementation and dissemination strategies to increase HIV testing and PrEP accessibility for
African Americans throughout the urban area of Houston.

Public health relevance
Project Narrative African American comprises a high burden of new HIV diagnoses in Houston. This pilot study aims to utilize implementation science methods to develop a pharmacy-led HIV testing and prevention service model to train pharmacy staff and overcome the current barrier to access to care for African Americans. The collaboration model between Research Centers in Minority Institutions and Centers for AIDS Research will enable leveraging resources to reduce health disparities in HIV prevention and care and train new HIV investigators. The ultimate goal is to develop implementation and dissemination strategies to increase HIV testing and PrEP accessibility for African Americans throughout the urban area of Houston.